Gastroenteritis virus infections in South African children: secretor status-linkedsusceptibility, prevalence and genetic diversity and humoral responses to norovirusinfection

Abstract
Norovirus, rotavirus and adenovirus are the major causes of severe viral gastroenteritis in children
worldwide. This project aims to monitor the prevalence, genetic diversity, predominant and
emerging strains of these viruses in South Africa (SA) over a 5-year period. In addition, the project
will investigate the humoral response to norovirus infections and determine to which norovirus
genotypes children in SA are exposed to in the first two years of life, and when protective
antibodies are generated. We will perform parallel gastroenteritis virus surveillance 1) in children
(<5 years of age) hospitalised with gastroenteritis, and 2) in wastewater influent from 11 sentinel
wastewater treatment plants across SA. Complete genomes of the predominant norovirus,
rotavirus and adenovirus genotypes will be determined by next generation sequencing to study
the global emergence and diversification of these viruses. A protein microarray approach will be
used to evaluate antibodies to a range of norovirus genotypes in children in SA. Dried blood spot
specimens from HIV exposed children that were submitted for HIV testing, will be accessed once
HIV testing is complete. Children will be classified in five age groups between birth and 2 years
of age. Initially we will characterise the immune response against 20 norovirus strains which
circulated in hospitalised children and in the environment in the recent past. The range of
norovirus genotypes will be expanded during the project to reflect the current strains detected in
clinical and environmental surveillance. In addition, the fucosyltransferase 2 (FUT2) secretor
status (which is linked to norovirus and rotavirus susceptibility) will be determined in an effort to
better understand the link between secretor status and infection with various norovirus and
rotavirus genotypes. Finally, the functionality of the detected antibodies will be evaluated in terms
of their avidity and ability to block binding between the norovirus major capsid protein (VP1) and
histo-blood group antigens. A luciferase-VP1 fusion protein immunoprecipitation assay will be
used to detect genotype-specific blocking antibodies. Seroprevalence and antibody
characteristics will be compared between the five age groups 0-1 month (maternal antibodies), 2-
6 months (maternal antibodies), 7-12 months, 13-18 months and 19-24 months. This project
should generate valuable data to better understand the diversity of norovirus infections and the
immune response to these infections in young children. The combination of seroprevalence
results with clinical and environmental data collected during the same time period will provide
valuable information on the importance of the environmental strains in norovirus exposure in
young children.

Public health relevance
Project narrative We will monitor five gastroenteritis viruses both in children hospitalised with diarrhoea, and in wastewater from 11 treatment plants in nine provinces of South Africa. We will characterise the strain diversity of adenovirus, norovirus and rotavirus, which cause the most severe disease. We will determine which norovirus strains children are exposed to between birth and 2 years of age as well as the functionality of their antibody response.